REFLECTANCE TOMOGRAPHY: TWO LAYERED TURBID MEDIA W/ DIFFUSE PHOTON DENSITY WAVES

An approach to the examination of the structure of layered biological tissue can be found in the measurement of the reflectance of plane diffuse photon density waves in the near-infrared range. The objective of this project is to take phase resolved reflectance measurements from both phantoms and biological tissues at moduolation frequencies of up to 2 GHz and to show the validity of the diffusion model to describe the measured phenomena. The technique allows the investigation of the structure of tissue to depths of 4-8 mm. A medical application may be found in improved examination techniques for deep burns as the method allows the investigation of the tissue structure without physical contact to the surface.